Administrative Supplement: Enhancing cell-type-specific inference with millions of snRNA-seq and deep learning methods

Abstract
The proposed Diversity Supplement will extend the original parent R01 in two aspects.
First, innovative deep learning models will be employed to perform aggressive
deconvolution to complement the empirical Bayesian method proposed in the parent
R01. Second, the Supplement will leverage additional single cell omics data that
became available after the funding of the parent R01. Specifically, we anticipate much
enhanced deconvolution using as reference newly published single nuclei RNA-
sequencing data, containing ~2.3 million nuclei from 427 donors.

Public health relevance
Project Narrative The proposed study will employ innovative deep learning (DL) models to enhance the inference of cell-type-specific gene expression profiles of Alzheimer’s Disease (AD), aiming to identify profiles that are associated to disease progression and regional vulnerability. Additionally, we will investigate cell-type-specific gene co-expression networks to uncover interaction patterns related to AD pathogenesis. This comprehensive approach will provide a detailed molecular- level analysis, furthering our understanding of the complex mechanisms underlying AD.